Lipidome composition, immune activation and subclinical vascular disease in Adolescents with perinatally acquired HIV in Uganda

Project Summary/Abstract:
There are 2.1 million children under 15 years living with HIV worldwide; the vast majority
have perinatally acquired HIV (PHIV) and reside in Eastern and Southern Africa. Children living
with PHIV are now expected to live through adolescence and well into adulthood, such that
adolescents now represent the largest growing population living with HIV. Several comorbidities,
including cardiometabolic, have been associated with heightened immune activation and
inflammation despite viral suppression in adults living with HIV. Because of the small size and
paucity of pediatric data, controversy exists regarding the mechanisms and the extent to which
heightened inflammation should be concerning in this young population during formative years.
Lipidomics analyses have revealed associations of lipid classes and fatty acid
composition with inflammation and several diseases, including cardiometabolic complications.
The overall goal of this project is to obtain new insight into PHIV and the factors associated with
immune activation and subclinical cardiovascular disease. We will use novel unbiased
analysis of integrated lipidomic and bring an innovative approach to identify signaling
cascades related to lipid processing that may predict cardiovascular complications in
PHIV. In a longitudinal study of 100 PHIV and age-and sex-matched uninfected controls, this
project aims to measure the lipidome over 96 weeks to identify lipid perturbations associated
with HIV and pathways associated with immune activation. We will investigate whether pro-
inflammatory lipids are predictive of subclinical vascular disease. Additionally, we will examine
the role of specific ART classes as well as individual antiretroviral drugs on the lipidome.
The proposed study leverages the rich data of Dr. Dirajlal-Fargo’s K23 study in Uganda.
This study will build on the well-phenotyped cohort of virally suppressed adolescents with PHIV
and age-and sex- matched uninfected comparison group and utilize repository specimens.
The longitudinal design will allow for data validation and replication, a major criticism of
prior observational omics studies. This study may reveal novel biomarker signatures of
biological, clinical, and prognostic relevance to prevent cardiovascular disease for adolescents
who are advancing into adulthood and have received long-term ART.

Public health relevance
Project Narrative Even with effective antiretroviral therapy, children and adolescents living with perinatally acquired HIV (PHIV) are at an increased risk of non-HIV related comorbidities. Our initial data in Uganda, has shown evidence of subclinical vascular disease at a young age in PHIV, however gaps remain regarding the underlying mechanisms. We will use integrative analytical approaches to explore the associations between the lipidome, immune activation and subclinical vascular disease over 96 weeks in Ugandan PHIV compared to age and sex matched uninfected adolescents. We seek to identify the pathophysiological contributions of individual lipid species to increase our knowledge of novel biomarkers for comorbidities in youth and reveal potential areas for targeted screening and interventions to improve cardiometabolic outcomes